Determining the effectiveness of a new model of PrEP initiation in Mississippi

PROJECT SUMMARY/ABSTRACT
The overall goal of this mixed-methods study is to examine the effectiveness of a same-day pre-exposure
prophylaxis (PrEP) initiation program in Jackson, Mississippi, and to explore barriers and facilitators to PrEP
initiation and retention in this model of PrEP delivery. HIV remains a critical public health problem in the United
States (US), with minimal decreases in HIV incidence in the past five years. There are substantial disparities in
HIV incidence and PrEP uptake in the US – by geography and race/ethnicity – that have persisted for decades.
Mississippi is one of seven states identified by the federal Ending the HIV Epidemic (EHE) initiative as a
“geographic hotspot” of HIV. MS has the sixth highest rate of new HIV diagnosis in the US, with the rate among
Black Mississippians being eight times higher than White Mississippians. In 2018-2019 we initiated a
pharmacist-led, same-day PrEP initiation program in Jackson to integrate same-day PrEP initiation at the time
of HIV testing, with a goal of facilitating rapid increase of PrEP uptake in non-clinical settings in Jackson. Over
75% of individuals who were offered same-day PrEP filled the prescription and about half were linked into
ongoing PrEP care. The program has continued operating with local funds, and new resources from the EHE
could be leveraged to expand Rapid PrEP. However, gaps in the model's evidence base limit its scalability
elsewhere. Here we propose a series of studies using prospective and retrospective data that will directly
inform whether resources should be allocated to scaling-up Rapid PrEP or to developing alternative models of
PrEP delivery. First, we will estimate the effectiveness of Rapid PrEP by examining PrEP persistence and HIV
incidence among individuals who initiated PrEP via Rapid PrEP (N=121) compared to a group of individuals
who initiated PrEP in a traditional “status quo” clinic-based model in Jackson, MS in 2015-2019 (N=475). We
will use prescription fill data to compare the 12-month PrEP persistence between the two groups. In sub-
analyses, we will restrict the population to those who were diagnosed with an STI after starting PrEP (a group
at high ongoing risk of HIV) and compare PrEP persistence. We will also use MS State HIV surveillance data
to compare HIV incidence between the two groups. Second, we will conduct 10-15 one-on-one qualitative
interviews with Rapid PrEP participants who disengaged from PrEP care to investigate the barriers and
facilitators to PrEP initiation and persistence. We will interview 3-4 Rapid PrEP participants who disengaged at
each step of the Rapid PrEP continuum (e.g., filling the prescription, initial linkage to clinical care, and
maintenance in PrEP care). Findings from these studies will direct the use of EHE resources to either scale-up
Rapid PrEP or to develop new models of PrEP delivery that can be operationalized in settings of low clinical
capacity.

Public health relevance
PROJECT NARRATIVE In this mixed-methods study in Jackson, Mississippi (MS), we propose to examine the effectiveness of a pharmacist-led, same-day PrEP initiation program compared to a status-quo clinic-based model. We will examine PrEP persistence, HIV incidence, and barriers and facilitators to PrEP initiation and persistence. Findings from this study will direct the use of federal Ending the HIV Epidemic Initiative resources to support new models of PrEP delivery that can be scaled-up statewide, which could have a substantial impact on the HIV epidemic in MS.